Flexible Funding Model - Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs

Project Summary/Abstract
Project Title: Flexible Funding Model - Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (U18) RFA-FD-18-001
Project Description:
To enhance and continue the current Nebraska Department of Agriculture (NDA) Food Safety
and Consumer Protection (FSCP) Manufactured Food Regulatory Program Standards (MFRPS),
and Food Protection Task Force (FPTF) programs.
This funding would allow NDA to achieve and maintain conformance with the most current
version of the MFRPS. The MFRPS help NDA ensure that the manufactured food regulatory
program uses best practices. Conformance with these program standards will help Nebraska's
program better direct regulatory activities at reducing foodborne illness hazards in plants that
manufacture, process, pack, or hold foods.
This funding would allow NDA to continue the work of the Food Protection Task Force in
promoting the integration of an efficient statewide human and animal food (HAF) protection
system that maximizes the protection of the public health. Efforts would include: fostering
communication, education, outreach, cooperation and collaboration within the state among
federal, state, local, tribal and territorial HAF protection, public health, agriculture, and
regulatory agencies, industry, academia, and consumers to initiate and/or support HAF protection
activities to improve public health.

Public health relevance
Project Narrative: Project Title: Flexible Funding Model - Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U18) RFA-FD-18-001 Although the United States has one of the safest food supplies in the world, the public health burden of foodborne disease in the nation is substantial. CDC estimates that each year roughly 1 in 6 Americans gets sick and 3,000 die of foodborne diseases. Nebraska Department of Agriculture (NDA) Food Safety and Consumer Protection (FSCP) Manufactured Food Regulatory Program Standards (MFRPS) focuses on prevention. The aim is to address risks throughout a product's life cycle, from the time a food is produced to the time it is distributed. We join FDA in its effort to ensure preventive approaches are effective. NDA FSCP's MFRPS program is working with the focus on three core elements: Prevention, intervention and corrective action, when a response in indicated. NDA has a yearly Food Protection Task Force forum which provides education for stakeholders of the state food protection system—regulatory agencies, academia, industry, and other interested parties to improve human and animal food safety and defense.